Mississippi State Department of Health MFRPS Flexible Funding Model-Infrastructure Maintenance Grant Application

Flexible Funding Model-Infrastructure Development and Maintenance for State Manufactured Food
Regulatory Programs
Summary/Abstract
Introduction
The Mississippi State Department of Health Division of Food Protection is applying for funding under the
cooperative agreement with the Food and Drug Administration, Funding Opportunity Announcement
(FOA) Number RFA-FD-23-027, Flexible Funding Model-Infrastructure Development and Maintenance
for State Manufactured Food Regulatory Programs.
The MSDH meets the eligibility requirements outlined in the FOA.
Discussion
Through the Manufactured Food Regulatory Program Standards (MFRPS) grant funds, the MSDH was
able to achieve full conformance in the ten MFRPS elements. The MFRPS cooperative agreement
allowed the MSDH to hire key personnel to execute the requirements of the MFRPS.
Results
Through previous MFRPS funding, the MSDH has investigated, developed, written and implemented
procedures for the regulatory program for MSDH MFRPS, Standards 1-10.
The Flexible Funding Model-Infrastructure Maintenance for State Manufactured Food Regulatory
Programs grant will provide the MSDH staff the resources needed to continue maintenance and
improvements to the MFRPS, Standards 1-10.

Public health relevance
Project Narrative The mission of the Mississippi State Department of Health is to promote and protect the health of the citizens of Mississippi. The funds provided through the Food and Drug Administration (FDA), RFA-FD-23- 027, Flexible Funding Model-Infrastructure Development and Maintenance for State Manufactured Food Regulatory Programs - will promote the continuation of a high-quality regulatory program while promoting the program’s ability to protect public health.